Morbidity Following Breast Cancer Treatment: A Prospective Study

The proposed outcome study will include: 1) a two year longitudinal, prospective design that includes a control group, 2) specific patient process variables such as demographics, medical data, e.g., staging conference information, and the standard upper body clinical examination, and 3) administration of a self-report surveys/questionnaire that measure upper limb functional limitations and disabilities, physical activity and quality of life at baseline and follow-up at 1, 3, 6, 12, 18 and 24 months. Women receiving medical care at Walter Reed National Military Medical Center who meet inclusion criteria are eligible for the study. Data available in these measurement domains will allow the researchers to determine the: 1) frequency and severity of: a) symptom distress (fatigue, pain including chronic pain, aching, weakness, burning, tingling, numbness, anxiety, and depression) and pathological conditions (adhesive capsulitis, weakness and atrophy, neuropathy, scar/skin adhesions, lymphedema), b) physical impairments (diminished upper extremity and trunk range of motion/flexibility, strength, coordination and increased girth), and c) functional imitations and disabilities during the course of the medical treatment (loss of independence in or ability to perform routine activities of daily living i.e., grooming, bathing, dressing, driving an automobile, and in some cases, return to their regular work, recreational and social activities). 2) level of impairment at which these patients have lost independence in function and identity those patients at higher risk for the loss of independence in function (e.g., ADL's), and 3) risk factors for loss of function and disability. Purpose: to examine the frequency and severity of problems in women with breast cancer for 2 years following initial medical treatment, including: l Physical impairments, such as loss of strength or flexibility, increased weight and swelling l Symptom distress, such as pain, fatigue and weakness. l Functional limitations and disabilities, such as loss of independence in activities of daily living (e.g., grooming, bathing, dressing, driving a car), work and social and recreational activities. to identify factors associated with these problems and try to determine their relationship to them. Collected data on 63 control subjects (goal of n=75)